Developing Human Induced Pluripotent Stem Cell Precision Oncology Models

Abstract
This proposal was specifically designed to support a dedicated Research Specialist with extensive experience
in human induced pluripotent stem cell (hiPSC) engineering to study the cellular and molecular mechanisms
underlying the formation and progression of central and peripheral nervous system tumors relevant to the
identification of risk assessment and personalized therapeutic strategies. This investigator has longstanding
expertise in RASopathy cancer predisposition syndromes, beginning with her doctoral studies focused on
generating Cardio-Facial-Cutaneous and Costello Syndrome zebrafish preclinical models, and over the past ten
years, initially as a postdoctoral fellow and now as an Assistant Professor on the Research track, in developing
translational research tools for the Neurofibromatosis Type 1 (NF1) cancer predisposition syndrome. As such,
the Research Specialist established and continues to expand the Washington University NF Center hiPSC
repository, which includes hiPSCs with patient-derived germline mutations, as well as engineered tagged or
conditional knockout lines, explicitly designed to define the molecular and cellular etiologies underlying NF1- and
RAS/MEK-associated nervous system cancers in children and adults. Leveraging the power of hiPSC
engineering, this Research Specialist has pioneered work demonstrating that (1) NF1 mutations are not
functionally equivalent in vitro or in vivo (cancer genetics), (2) NF1-mutant neurons drive low-grade nervous
system tumor growth in an activity-dependent manner (cancer neuroscience), (3) neurons function as immune
activators to establish an immune cell axis supportive of brain tumor growth (cancer immunology), (4) targeting
neuronal excitability provides new options for the treatment of brain and nerve tumors (cancer therapeutics), (5)
hiPSCs can be exploited to develop novel humanized models of low-grade brain and nerve tumors (cancer
modeling), and (6) hiPSC cancer modeling revealed a chemokine circuit critical for patient-derived low-grade
brain tumor xenograft generation (precision oncology). Moreover, multi-institutional international dissemination
of these unique tools has galvanized new research directions within the Program Director’s laboratory, critical to
the successful acquisition of new NCI grant funding and the establishment of new international collaborations.
Finally, the Research Specialist’s commitment to the field, continued leadership in this scientific area, and critical
importance in guiding hiPSC-based projects, both at Washington University and worldwide, will continue to
provide clinically-actionable opportunities relevant to personalized risk assessment and medical management of
people with RAS-related oncologic disease.

Public health relevance
Project Narrative This proposal is designed to support a dedicated and experienced Research Specialist who is leading numerous initiatives that employ human induced pluripotent stem cell engineering to study the pathogenesis of nervous system tumors. The outcomes of these studies will continue to provide clinically actionable opportunities relevant to personalized risk assessment and medical management of RAS-related oncologic disease.